Pseudouridine detection with single-base resolution in a multiplexed epitranscriptomics assay

ABSTRACT
Chemical modifications to the canonical nucleosides are found throughout human RNA and collectively
constitute the epitranscriptome. They are critical regulators of RNA function in many cellular processes, including
RNA translation, splicing, processing, trafficking, stability, and degradation. RNA modifications play a central role
in cellular and organismal development, homeostasis, and disease and have been linked to cancer, metabolic
and neurological diseases, and viral infection. RNA modifications, and the pathways in which they are involved,
are now being exploited in the development of novel therapeutics, especially cancer chemotherapies, and
present new opportunities to develop clinical biomarkers. However, much of the opportunity to understand and
use the epitranscriptome to advance human health is held back by limitations of the available tools for detecting
and locating these modifications. There are no currently available high-throughput methods that can
simultaneously profile multiple modifications and are readily accessible to researchers doing RNA sequencing.
In this project, we will develop and commercialize an assay for the simultaneous detection and quantification of
the three most prevalent modifications in RNA: N6-methyladenosine (m6A), inosine (I), and pseudouridine (Ψ).
Our strategy leverages a combination of engineered RNA modification-specific binders and enzymatic
conversion of Ψ to enable pull-down of modified RNA fragments onto mod-specific beads, barcoding to record
the presence of the modification, next-gen sequencing of the resulting library, and analysis with custom
bioinformatics tools. The expected outcome of this project is the full commercial launch of the AlidaBio EpiPlex
v2 assay, which adds Ψ detection to our platform, enabling any researchers doing RNA-seq to include the
detection, location, and relative quantification of m6A, I, and Ψ in their analysis with ≥ 10 ng of polyA-selected
RNA or ≥ 200 ng total RNA input.

Public health relevance
Project Narrative Alida Biosciences is developing a commercial platform that enables researchers to read the epitranscriptomic code, a crucial layer of biological regulation governing genetic expression in cells, both in health and disease. This project focuses on the development of a commercial assay that enables simultaneous detection and relative quantification of the three most prevalent RNA modifications in mRNA, N6-methyladenosine (m6A), inosine (I), and pseudouridine (Ψ). This assay, EpiPlex v2, will enable any researchers doing RNA sequencing to advance our understanding of disease progression, identify new types of diagnostic biomarkers, and accelerate drug development.